Lead Optimization of DHODH Inhibitors for Malaria

Project Summary. Malaria puts at risk 50% of the world’s population and is responsible for nearly 600,000
yearly deaths, mostly in children under the age of five in Africa. While a large portfolio of anti-malarial agents
has been used to combat the disease, drug resistance has compromised the effectiveness of most clinically
approved drugs, and the recent identification of resistance alleles against the current front line artemisinin
combinations in Africa threatens current disease control programs. Thus, the identification of new drugs to
combat drug resistant malaria is essential to continued progress against the disease. Our group in
collaboration with Medicines for Malaria Venture (MMV) validated dihydroorotate dehydrogenase as a clinically
valuable drug target for the treatment of malaria through studies on triazolopyrimidine DSM265, which
advanced to phase II clinical development before the project was stopped due to discovery of off-target toxicity
in preclinical species. In this current proposal we are working to identify new generation DHODH inhibitors by
focusing on a different chemical series from DSM265, thus not expected to share an overlapping toxicity profile.
Secondly, we plan structure-based approaches to identify inhibitors that will have reduced resistance risk
compared to DSM265, which selected for resistance in 2 patients treated in the Phase II study. In aim one we
plan to complete lead optimization of three related pyrazole-based DHODH inhibitor series, identified by
scaffold hop using computational approaches (in collaboration with Schrödinger) from a pyrrole series we
completed work on during the current fund period. Compounds from our pyrazole series have demonstrated
high potency (sub nanomolar to low micromolar), and a reduced propensity to select for resistant parasites in
vitro. We have a strong understanding of the SAR around these series, including the potency drivers, and the
metabolic hot spots, and we plan mix and match chemistry to identify compounds with improved metabolic
stability that will support human half-life (>100 h) and dosing targets (< 500 mg) set out by MMV. In aims 2
and 3 we use a combination of experimental and computational approaches (Schrödinger) to define the
enzyme:ligand kinetic and thermodynamic binding properties that are associated with reduced resistance risk,
as well as to correlate resistance risk to compound physical chemical properties. Computational models and
measured thermodynamic/kinetic parameters will inform design and synthesis of new compounds predicted to
have reduced resistance risk. The DHODH program is ideally suited to study the contribution of binding
energetics to resistance propensity, as we have a wealth of structural information over three different chemical
series with different physical chemical properties and alternative binding modes to the enzyme active site.
Successful completion of these aims will allow identification of the strongest DHODH candidate for further
clinical development, and it will provide key learnings on how to navigate resistance issues in target-based
drug discovery programs for proliferative diseases in general, increasing the impact of our studies.

Public health relevance
Project Narrative. Our program seeks to identify novel inhibitors of malaria dihydroorotate dehydrogenase (DHODH) to combat the continuing threat of drug resistant malaria to clinical control of the disease. Our lead optimization program has identified potent compounds with reduced resistance risk compared to past DHODH inhibitors, and we are currently optimizing the series to identify compounds with the properties needed to support dosing in humans. We also plan to use computational and experimental approaches to identify features of enzyme/ligand interactions that can inform design of drugs with reduce resistance risk, allowing us to identify a candidate for development with the best chance to avoid clinical resistance.